Laser-Engraved Wearable Sweat Sensors to Detect and Monitor Cardiometabolic Disease

PROJECT SUMMARY
Metabolic syndrome is on the rise as the leading cause of morbidity and mortality, affecting more than a third
of all U.S. adults. If untreated, patients who develop type 2 diabetes mellitus (T2D) are at high-risk for major
adverse cardiovascular events, including stroke, myocardial infarction, and cardiovascular related deaths.
Despite chronic screening and monitoring for patient-specific prediction and prevention for cardiometabolic
disease, there remains a bottleneck to detect and monitor the metabolic risk factors underlying the rising
epidemic of obesity-associated with hyperlipidemia, hypertension, and diabetes. For these reasons,
developing wearable molecular sensors, which allow for seamless screening, monitoring, and potentially
enables timely intervention, is clinically significant to confront the rising endemic of cardiometabolic disorders.
In this project, we propose to continuously monitor a panel of key metabolic biomarkers including glucose,
uric acid, branched-chain amino acids (BCAAs: leucine, isoleucine, and valine), and insulin using an
integrated Molecular Sensing System (iMSS). We hypothesize that seamless detection of cardiometabolic
biomarkers accelerates our capacity to identify metabolic risk factors in our prediabetic patients with obesity
for early nutrition intervention to reduce health disparities in the U.S. In addition to integrating with our existing
glucose and uric acid sensors, we propose to develop novel laser-engraved wearable sensors for continuous
monitoring of BCAAs and insulin based on a novel nanobiosensing approach that combines high-throughput
laser-fabricated graphene, molecular imprinting based ‘artificial antibody’, and in situ sensor regeneration
technique. This approach will enable large-scale, low-cost fabrication of highly sensitive and selective sensors
for continuous monitoring of clinical meaningful cardiometabolic analytes in human sweat at ultralow
concentrations (such as BCAAs). The use of laser-induced microfluidics and numerical simulation-guided
design optimization enables efficient fluid sampling with minimized effects from the sensing delay and fluid
evaporation. Harnessing the power of concurrent multiplexed cardiometabolic sensing, adjusted
electrochemical measurements based on pH, electrolytes, temperature, and sweat rate calibration minimize
the systematic uncertainties persisted in the current generation of wearable sensing systems. We will validate
the correlation of the sweat/blood biomarkers in healthy subjects using the iMSS and deploy these epidermal
sensors to the high-risk patients. We envision that the iMSS system will provide an entry point to identify pre-
diabetes and obesity at risk for conversion to T2D, and will have translational significance to mitigate clinical
manifestation of major adverse cardiovascular events.

Public health relevance
PROJECT NARRATIVE This project aims to develop a laser-engraved wearable molecular sensing patch that can continuously monitor a panel of key cardiometabolic biomarkers. This project spans across chemistry, engineering, cardiovascular medicine, and clinical nutrition to explore the novel method of monitoring key cardiometabolic biomarkers in patients with pre-diabetes and obesity. This platform has the potential to modulate the patient-specific cardiometabolic risk factors in the pre-diabetic and obese individuals, with translational significance to mitigate clinical manifestation of major adverse cardiovascular events.